Oklahoma IDeA Network of Biomedical Research Excellence

This renewal application for the Oklahoma IDeA Network for Biomedical Research Excellence (OK-INBRE) proposes to further enhance the statewide research infrastructure and biomedical research capacity in Oklahoma by i.) enhancing and strengthening the research environment and building biomedical research capacity and research infrastructure at network institutions; ii.) providing support for faculty research and research mentoring to strengthen biomedical research excellence and expertise throughout Oklahoma; and iii.) providing research opportunities for students to help develop a strong biomedical research workforce in Oklahoma. The OK-INBRE Network is comprised of two research intensive institutions, the University of Oklahoma Health Sciences Center (OUHSC) and the Oklahoma Medical Research Foundation (OMRF). These institutions are integrated and aligned with six Primarily Undergraduate Institutions (PUIs) and four Community Colleges (CCs) that are essential to the success of the OK-INBRE network. The OK-INBRE network will continue to educate large numbers of students from institutions throughout Oklahoma and train the next generation of biomedical researchers. OK-INBRE will provide significant research resources to seven Research Project Investigators (RPIs), two from OUHSC/OMRF and five from the network PUIs. Specific career development mentors will help the RPIs achieve scientific independence. In addition, pilot project grant awards for research and equipment will be provided to PUI faculty annually. Support for 35 undergraduate students also will be provided each year to provide a vibrant and dynamic summer undergraduate research program. OK-INBRE will support Data Science and Proteomics Core facilities that will serve as statewide research and educational resources to provide faculty, trainees, and students throughout the state with access to the computational tools needed to enhance multidisciplinary biomedical research in Oklahoma. Uniquely, the Proteomics Core will not only play a central role in training the next generation of researchers in Oklahoma, but it will also be used as a resource for investigators in all IDeA-eligible states. Through workshops, seminars, research training, mentoring, and access to state-of-the-art core facilities, the OK-INBRE program will continue to enhance infrastructure and research capacity while building Oklahoma’s biomedical research workforce.

Public health relevance
The Oklahoma IDeA Network of Biomedical Research Excellence (OK-INBRE) is a network of research-intensive institutions, Primary Undergraduate Institutions (PUIs), and Community Colleges (CCs) in Oklahoma that are building critical research infrastructure and providing training, research productivity, and career development of biomedical researchers and undergraduate students. OK-INBRE-funded investigators are invested in numerous projects that span cancer, infectious disease, autoimmunity, diabetes, and aging. Collectively, the OK-INBRE program supports several biomedical research topics that will further the health of Oklahomans.